BONE DENSITY IN CONGENITAL ADRENAL HYPERPLASIA

This study is designed to determine bone density in patients with congenital adrenal hyperplasia and the progression of bone loss, over time in response to treatment.